AGE/GENDER EFFECTS ON SAFETY, TOLERANCE, AND PHARMACOKINETICS OF BAY X3702

Evaluate the safety, tolerability, pharmacokinetics and pharmacodynamics of BAY x3702 in healthy elderly subjects for possible future use in treating stroke.